Administrative Core

Summary
The goal of Administrative Core in Phase 2 is to continue centralizing and managing resources necessary to
enhance the success of the COBRE on Host-pathogen Interactions (HPI). Building on the success of Phase 1,
this Core will provide support to investigators focused on determining the mechanisms underlying immune
modulations in the host upon interaction with various microbes to identify possible treatments for devastating
inflammatory diseases. Specifically, the concerted effort will focus on (1) expanding the research enterprise of
this center by supporting and recruiting junior investigators working on host-microbe interactions that are central
to human health and diseases; (2) facilitating productive scientific interactions by organizing networking
opportunities through annual symposium and seminar series ; (3) providing an individualized and tailored
mentoring program for each investigator; 4) providing oversight and support for mentoring programs through
Internal and External Advisory Committees with regular meetings; 5) raising the national profile of the group by
providing cutting edge infrastructural support; 6) establishing a new Computational Data Analysis Core facility to
provide cutting-edge bioinformatics analytical and interpretative support for the group; 6) providing administrative
support to the existing Cores (Histology, Imaging and Flow Cytometry; and 7) fostering collaboration between
the other North Dakota COBRE, INBRE and CTR DaCCoTA grant supported groups and between individuals in
the respective groups. Successful completion of these goals in Phase 2 of our COBRE will elevate this center to
a nationally recognized level with a group dedicated to understanding various aspects of host-microbe
interactions in human health and disease. With the recent funding of a Phase 2 Epigenetics COBRE and a Phase
I Clinical Translational Research Center DaCCoTA, our HPI COBRE Phase 2 has an unprecedented opportunity
at hand to execute high-quality, cutting edge research of immense therapeutic and clinical potential.

Public health relevance
Narrative The Administrative Core of this Phase 2 COBRE will provide oversight support to Core service providers and junior investigators focused on determining the mechanisms underlying immune modulations in the host upon interaction with various microbes. Our long-term goal is to identify possible treatments for devastating inflammatory diseases.